PLACEBO CONTROLLED SAFETY AND EFFICACY STUDY OF PIMAGEDINE--TYPE II DIABETES

To determine the safety and efficacy of this hydrazine compound to prevent and/or stabilize or improve the parameters of diabetic nephropathy (proteinuria and diminishing renal function).